Histopathology

Core A takes care of the tissue processing needs for all projects. It is directly supervised by Dr. Pelayo Correa and his assistant Dr. M. Blanca Piazuelo. In Nashville our personnel receive all biopsies from Colombia. Biopsies for histopathology evaluation are fixed immediately in buffered zinc-formalin, embedded in paraffin, sectioned and stained with hematoxylin eosin and modified Warthin- Starry silver stain. Biopsies for frozen sections are received in OCT and frozen immediately. The laboratory performs all immunohistochemical stains, including Ki67, TUNEL assays, inducible nitric oxide synthase, nitrotyrosine and a variety of white blood cell markers. Fully trained and experienced personnel are available for all procedures.

Public health relevance
The damage done by infection to the stomach lining is examined by taking small pieces (biopsies) of the mucosa with the gastroscope. These biopsies are processed by this core to be examined under the microscope by the investigators